Engineering durable immunity by optimizing HIV vaccine parameters to drive long-lived plasma cell development

PROJECT SUMMARY
The HIV pandemic has been raging for nearly forty years, and despite immense effort we have yet to discover a
vaccine that can induce durable, protective immunity. HIV remains an urgent global health crisis, with 38 million
people living with HIV and 1.5 million people newly infected each year. For most infectious diseases but
particularly HIV, vaccines are preferable to other forms of prevention or prophylaxis because of their potential
durability. Ideally, a single immunization induces protective immunity that lasts for years or even decades.
Antibodies are the primary mechanism of protection for nearly all available vaccines, so when considering
vaccine durability, an important measure is the length of time that neutralizing antibodies can be maintained at
a functional level. In this proposal, we will systematically study the effects of different vaccine parameters on
antibody durability. In Aim 1, we will evaluate immunogen affinity and valency. In Aim 2, we will investigate
adjuvants and vaccine platforms, including mRNA delivery. In Aim 3, we will explore dosing regimens, including
promising escalating-dose strategies.

Public health relevance
PROJECT NARRATIVE The HIV/AIDS pandemic, which continues to infect 1.5 million people annually and affects over 38 million worldwide, has been ongoing for four decades and we still lack an effective vaccine that can provide long-lasting protection. In this proposal, we will systematically investigate how different vaccine components and delivery methods influence the immune system's ability to produce durable antibody responses. Using a structured and well-controlled environment for studying these factors, we hope to accelerate progress toward an effective HIV vaccine that reliably induces durable protection.